The Development of Individual Differences in Adolescent Brain Structure and Risk

Abstract
Individual differences in brain structure, including cortical morphology and the white matter
connectome are associated with risk for psychiatric disorders. The first year of life is a period of
rapid and dynamic structural and functional brain development and new data from our cohort
suggests that a large portion of individual differences in brain structure in 10 and 12 year olds is
already present in the first year or two of life. Early adolescence and puberty is the second major
period of postnatal brain development, characterized by dynamic structural and functional brain
maturation and reorganization, and emerging risk for psychiatric disorders, though it is not known
how this period of development contributes to individual differences in brain structure and risk.
The UNC Early Brain Development Study is a unique and innovative longitudinal study that has
followed children, enrolled prenatally, with imaging and cognitive/behavioral assessments at birth,
1, 2, 4, 6, 8 and 10 years. 482 children from this cohort are now reaching adolescence, and we
propose to follow these children at 12, 14 and 16 years of age. MRIs, including structural, diffusion
tensor, and resting state functional imaging, will be performed. Cognitive and behavioral
development will be assessed, with a focus on the phenotypes of executive function, attention,
and anxiety, consistent with RDoC constructs important for psychiatric disorder risk. We will
determine how adolescent brain development contributes to individual differences in relation to
early childhood development and whether the white matter connectome is a useful early imaging
biomarker. Knowledge gained in this study will improve our basic understanding of human brain
development, and ultimately inform early intervention strategies that prevent or mitigate risk and
illness severity.
Relevance
New knowledge gained in this study will provide a dramatically improved framework for
understanding childhood brain development and its relationship to cognitive and behavioral
outcomes in adolescence, and to risk for subsequent psychiatric disorders.

Public health relevance
Project Narrative For years it has been hypothesized that psychiatric disorders are the result of abnormal trajectories of childhood brain development, though there is little direct evidence to support that hypothesis. The UNC Early Brain Development Study is a longitudinal study that has followed children with imaging and developmental assessments from birth to age 10 years. We will study brain structure and function in these children at 12, 14, and 16 years with MRI to see if we can identify childhood predictors of behavior in adolescence that is considered at risk for psychiatric illness, which will ultimately help target periods of childhood development for early intervention.